DOUBLE BLIND, PLACEBO CONTROLLED, RANDOMIZED STUDY ON EFFICACY OF IBANDRONATE

The purpose of this three year phase III study is to investigate the therapeutic effect Ibandronate in the long term treatment of postmenopausal osteoporosis by evaluating the efficacy of long term intermittent and long termcontinuous oral treatment using the incidence of new vertebral fractures as the primary endpoint. The specific objectives to determine whether Ibandronate prevents fractures and bone loss in women with established postmenopausal osteoporosis, to determine the type of side effects associated with the oral administration of Ibandronate.